Defining the Substrates and Interactome of Focal Adhesion Kinase that Regulate Exocytic Vesicle Fusion

PROJECT SUMMARY
Developing neurons achieve a complex, elongated morphology, involving substantial increases in plasma
membrane surface area that far exceed the accompanying growth in cytoplasmic volume. We have previously
shown that during exocytosis, the fusion of secretory vesicles provides sufficient membrane material for
developmental plasma membrane expansion. Similar to the synapse, the synaptic SNARE proteins, VAMP2,
syntaxin1, and SNAP25 are present in developing neurons and mediate vesicle fusion. At the synapse, several
synaptic vesicles are tethered to the presynaptic plasma membrane, representing the readily releasable pool.
Their synchronous fusion and release of neurotransmitter is evoked by a Ca++ spike. In contrast, in developing
neurons, our studies have demonstrated that fusion is not synchronous, and single vesicle fusion events occur
in what has previously been considered a constitutive manner. However, we recently reported a surprising
requirement for the activity of the nonreceptor tyrosine kinase focal adhesion kinase (FAK) in promoting vesicle
fusion, in particularly during the transition between SNARE complex formation and vesicle fusion. The goal of
this proposal is to investigate how FAK scaffolding function and/or FAK kinase activity regulates SNARE
complexes and exocytosis. Our work utilizes neuronal cultures, multiple modes of light microscopy to visualize
single vesicle fusion events at high spatial and temporal resolution, and quantitative mass spectrometry.
Completion of this work will provide fundamental information about regulation of exocytosis during neuronal
development.

Public health relevance
PROJECT NARRATIVE In developing neurons, the fusion of secretory vesicles with the plasma membrane is critical for plasma membrane surface area expansion as neurons achieve complex, elongated morphologies. Previously this fusion has been considered constitutive, however our recent findings suggest fusion is triggered by focal adhesion kinase (FAK). The goal of this proposal is to define the substrates and interactome of FAK to identify novel regulators of constitutive exocytosis, and define how FAK broadly regulates exocytosis and cellular shape change.